Mindfulness and Cognitive Behavioral Therapy for Sleep in Cancer

Hematologic cancer patients are at high risk for developing insomnia and daytime fatigue, pain, and distress in
the months after inpatient treatment. Extended hospitalization for chemotherapy can activate predisposing
factors (e.g., hyperarousal) and precipitate poor sleep patterns. Lack of sleep and subsequent worry about
poor sleep quality may negatively impact daytime fatigue, pain, and distress, and lead to problematic behaviors
that further exacerbate insomnia (e.g., napping/extended time in bed, medication use). Sleep difficulties can
become chronic as patients struggle to disengage from thoughts about insomnia and its interference to valued
activities. Chronic insomnia places cancer patients at elevated risk for disease progression. Mindfulness-Based
Therapy for Insomnia (MBTI) is new group-based treatment that combines sleep restriction and stimulus
control with mindfulness principles and meditations to treat insomnia, reduce rumination, and promote positive
responses to poor sleep (e.g., less time in bed, less medication). To date, MBTI has not been applied to
hematologic cancer patients who are particularly prone to both nighttime sleep disturbance and daytime
fatigue, pain, and distress in the months following discharge from inpatient chemotherapy. Adaptations to MBTI
are warranted to better address the unique challenges facing immunosuppressed hematologic cancer patients
with insomnia, fatigue, pain, and distress after demanding inpatient treatments. The proposed study seeks to
adapt and assess an MBTI protocol that includes mindfulness-based sleep techniques and training in coping
skills for daytime fatigue, pain, and distress. Participants will be hematologic cancer patients endorsing
insomnia, fatigue, pain, and distress 1-4 weeks after discharge from inpatient chemotherapy. Phase I aims to
use information gathered from patient (N=3) and provider (N=1) focus groups to adapt MBTI for individual
treatment and improved symptom management. Intervention content and procedures will be further refined
through iterative user testing (N=5). We hypothesize these activities will result in a manualized, adapted MBTI
protocol including patient materials and a structured therapist manual to standardize the intervention. Phase II
aims to conduct a single-arm pilot study (N=30) to assess the feasibility, acceptability, and examine pre- to
post-intervention outcomes. We hypothesize that participants will report improvement in the primary outcome
of insomnia symptoms (i.e., severity and interference) and secondary outcomes (i.e., fatigue, pain, anxiety and
depressive symptoms, hyperarousal, mindfulness, and self-efficacy for symptom management). Consistent
with the National Cancer Institute’s mission to reduce suffering from cancer, this project initiates a program of
research focused on critical symptom management needs for the understudied hematologic cancer population.
Positive results from this study would provide support for a larger, methodologically rigorous randomized
efficacy trial. Future work might examine the effects of adapted MBTI on neuroendocrine and immune markers
that are linked to sleep and have implications for cancer progression.

Public health relevance
Project Narrative Treatment for hematologic malignancy involves a rigorous 4 to 6-week hospitalization for induction chemotherapy that can leave patients with significant insomnia and daytime symptom burden (e.g., fatigue, pain, and distress) once discharged home. Chronic insomnia puts cancer patients at elevated risk for disease progression, yet treatment for insomnia in cancer is often limited to suboptimal pharmacological approaches. Behavioral interventions for insomnia are efficacious and cost-effective, though understudied in this vulnerable population; the proposed research addresses critical symptom management needs of hematologic cancer patients by adapting and testing an intervention that combines mindfulness-based sleep techniques with behavioral symptom management strategies to treat both nighttime sleep disturbance and daytime fatigue, pain, and distress reported 1-4 weeks after discharge from inpatient chemotherapy.